CONTROL OF GENE EXPRESSION IN CELLULAR SENESCENCE

The long-range goal of this program project grant is to understand the basic molecular mechanisms involved in human cellular senescence and the reverse phenomenon of immortalization. The specific aims are to: 1) Bring together five individual laboratories using disparate model systems of cellular senescence: normal human fibroblasts, adrenocortical cells and melanocytes and various immortal human cell lines; to work together on similar goals, using common techniques and approaches to answer questions regarding the molecular and cellular mechanisms involved in senescence and immortalization. These studies will examine the changes in gene expression that occur in cells as they are in vitro and in vivo, and will establish the differences and similarities in the pathways that lead to inhibition of cell proliferation. 2) Provide core facilities that are requisite for all the projects and thereby consolidate resources that will benefit the research at a much lower cost. The aims of a program project will thereby be met, encouraging successful interactions and enhancing the utilization of common resources. 3) Provide a formal mechanism to promote research interactions via joint planning meetings.